Novel Prostate Cancer Cell Lines to Address Prostate Cancer Disparity in Black Men

This work is based on the hypothesis that to fully exploit the benefit of cell line-based drug
screening, a representative cell line panel recapitulating the varied types of prostate cancer (PCa)
and the contribution of differences in ancestry is necessary. PCa is the leading cause of cancer
mortality in men worldwide. Current advances in patient diagnoses and therapy have led to a
decline in PCa incidence and mortality rates. However, this is not the case for men of African
ancestry (MAA) from Africa and the Caribbean where both PCa incidence and mortality rates are
on the rise. PCa cell lines are used to understand the biology of PCa and to advance the
development of PCa theranostics. However, more than 97% of the PCa cell lines that are readily
available to researchers are from men of European ancestry (MEA). There continues to be limited
representation of PCa materials from MAA when compared to MEA, and there are almost no cell
models available derived from MAA. This makes it difficult to assess the efficacy of potential
treatments in MAA versus MEA, contributing to a problem in health disparities. To address this
problem, this project will first develop and characterize cell lines that recapitulate the most
prevalent molecular abnormalities associated with PCa in MAA (Aim 1). Second, it will
comparatively screen chemotherapy drugs and Jamaican natural lead molecules on the novel
MAA PCa cell lines to standardly employed PCa cell lines derived from MEA (Aim 2).

Public health relevance
The lack of representation of samples from men of African ancestry (MAA) at preclinical and clinical research is believed to contribute to the higher incidence and mortality rates of prostate cancer among MAA. As cell lines are tools used to understand the biology of tumours from which they are derived as well as to develop theranostics, the under-representation of these need urgent rectifying. This project seeks to develop novel MAA cell lines that will aid in developing novel therapies from Jamaican natural products for MAA with PCa, a patient population with the highest incidence and worst mortality rates for PCa.